Multiomic Framework for Glaucoma

Primary open-angle glaucoma (POAG) produces chronic, progressive, and irreversible optic nerve
degeneration, leading to visual disability and blindness. We propose to analyze preclinical proteomic and
metabolomic markers and their interactions with glaucoma genetic predisposition to better understand POAG
pathophysiology. We will use plasma samples from a matched case-control group (500 cases and 500
controls) nested within ongoing prospective cohorts (Nurses' Health Study (NHS), NHS2, and Health
Professionals Follow-up Study) as well as genetic data and prospectively collected biennial questionnaire data
and clinical data on incident glaucoma cases. For incident POAG cases, we have used an artificial intelligence
algorithm to define POAG subtypes by visual field loss patterns; the POAG subtype with paracentral visual field
is of particular interest, as this subtype is more strongly associated with considerable functional disability. This
study will employ a cutting-edge platform that uses slow off-rate modified aptamer reagents, which bind
proteins like antibodies to quantify 5,000 proteins (Aim 1). In addition to an untargeted approach, we will test a
priori hypotheses in targeted approaches to investigate the relation to POAG for proteins related to nitric oxide
signaling, lipid metabolism, and immune response. We will then test the hypothesis that dysregulation of lipid
metabolism is important in POAG etiology by using a commercial NMR metabolomics platform assaying 168
metabolites that quantify metabolites in 3 categories: a) low molecular weight molecules like ketone bodies; b)
lipoproteins like high-density lipoproteins of specified particle size; and c) plasma lipids (Aim 2). We will use
preclinical plasma collected ~10 years before diagnosis in 600 cases and 600 controls who previously
underwent high throughput genotyping and LC/MS metabolomics. For Aims 1 and 2, we will explore whether
associations vary by visual field loss patterns in POAG. Lastly, in NHS, NHS2, and HPFS, participants with the
top 10% of the POAG polygenic risk score (PRS) had a 10+ fold higher risk of POAG; yet ≥70% of those in the
highest PRS did not develop POAG and are “resilient to high POAG polygenic risk”. We will evaluate the
biomarker signature and ophthalmic features associated with this resilience in those with the highest POAG
PRS scores (Aim 3). We will seek nominal replications for all aims in the UK Biobank. The aims will expand
the repository of multiple `omics data available for preclinical glaucoma. The proposed aims are significant
and innovative, as analyses of prospective proteomic and metabolomic markers, in combination with genetic
and clinical phenotype data to subclassify POAG, will advance our understanding of POAG etiology.

Public health relevance
Primary open-angle glaucoma (POAG) is an intraocular pressure-related, chronic optic neuropathy that produces visual disability of public health importance. We will submit plasma collected before POAG diagnosis to state-of-the-art proteomic and metabolomic platforms. The biomarker data generated will be combined with genomic markers to gain insight into POAG etiology.